A Mixed-methods Approach to Understand the Interplays of Social and Physical Environments, Loneliness, and Cognition among Older People with HIV

PROJECT SUMMARY
There is a rapid growth in the graying of HIV population in the United States who are at increased risk for
cognitive impairment. Loneliness is a risk factor for cognitive deficits, and older people with HIV report
significant loneliness. Despite the well-established associations between loneliness and cognition, the findings
specific to older people with HIV only have implications for overall cognition and are cross-sectional in nature,
limiting the understanding of the longitudinal effects of loneliness on cognition and on specific cognitive
domains over time. The ecological theory of aging posits that an individual's well-being and health as one
grows older are shaped by the interplay and dynamic exchange of person- and environment-level factors. As
such, social and physical environments have the potential to affect and mutually reinforce loneliness and
exacerbate downstream cognitive health, yet it has not been empirically studied. My long-term career goal is to
enhance overall health and well-being of the aging HIV population by identifying and intervening on modifiable
factors across multiple levels of influence. Building on my prior cross-sectional research on social isolation and
loneliness in older people with HIV, the proposed mixed methods research will uncover the influences of
social/physical environment-level factors on, and elicit perspectives to add rich description to, the relationship
between loneliness and cognition in older PWH. I will leverage the unique strengths of an ongoing prospective
R01 study that examines multiple indices of social connections on HIV control and is nested within the
Multicenter AIDS Cohort Study/Women's Interagency HIV Study Combined Cohort Study. Guided by
multidisciplinary mentors with complementary and synergistic expertise, I will pursue the following research
aims: among older people with HIV (≥50 years old), 1) determine the longitudinal patterns of loneliness and
cognition over time; 2) identify social and physical environment-level factors related to loneliness and cognition;
and 3) elicit perspectives of how person- and social/physical environment-level factors affect cognitive health
and how narratives of loneliness subgroups vary. Complementing this research, a detailed training plan will
include 1) the science of cognition within the context of HIV and aging; 2) assessment of social and structural
level factors ; 3) longitudinal data analytic skills; and 4) mixed-methods and community-engaged research. The
protected time afforded by K01 will equip me with the necessary skills to launch an independent research
career that incorporates socio-structural determinants into the study of HIV and aging. Findings will provide
critical insights into understanding the complex, multifactorial contributors to the link between loneliness and
cognitive health in older people aging with HIV. The results will inform subsequent R-level grants toward
expanding and translating the findings to stakeholder groups and, ultimately, developing effective strategies
that seek to improve the health and well-being of older PWH.

Public health relevance
PROJECT NARRATIVE HIV has changed its course into a chronic condition associated with multimorbidity that is closely tied to cognitive deficits. Examining loneliness, a modifiable risk factor for cognitive deficits, and the interplays of multi-level (person, social environment, and physical environment-level) influences on the link between loneliness and cognition in older people with HIV could provide a new way to understand and improve cognitive health. Ultimately, these findings will inform development of future targeted interventions to enhance health and well-being of this vulnerable population.